Core--Histopathology/Physiology

DESCRIPTION (provided by applicant): This Core is intended to integrate the disparate functions of a number of skilled personnel already present at the Children’s Hospital. Core B will provide pathology/histology collaboration for each investigator to determine any gross and microscopic abnormalities of the mouse models and changes in gene expression. Murine cardiovascular physiology, both noninvasive and invasive will also be provided. All of the Projects will use this core. The two Co-Directors, Dr. Melissa Colbert and Dr. Timothy Hewett, are expert in the fields of murine cardiac histology/embryology and murine physiology, respectively. Both have been involved in a number of important collaborations over the years with PPG personnel (see Introduction). Dr. Colbert will lead the histology/embryology facets of the Core while Dr. Hewett will direct the physiology component.